Career Development Program

The SPORE Career Development Program seeks to assist faculty investigators with clear potential to benefit breast cancer research. This Program provides its awardees with direct funding support, access to SPORE Cores, career advice/mentoring, and facilitation of potential collaborations with other SPORE projects and investigators. Career Development awardees are either promising junior investigators embarking upon research careers involving breast cancer, or more established investigators who have developed a new interest in translational breast cancer research. Individuals are selected through a formal application process involving peer review by the SPORE Career Development Program Committee and ad hoc reviewers.